Core Grant for Vision Research

SUMMARY
The overall goal of our Vision Research Core is to provide expertise, facilities, and equipment to foster and
expand vision research at the University of Wisconsin-Madison. This will be accomplished by three Cores.
The Ocular Omics and Quantitative Molecular Biology Core will facilitate the use of qPCR, Laser Capture
Microdissection, RNASeq, microarrays, NextGen Sequencing, Flow Cytometry and other molecular methods
by core users. The Pathology and Imaging Core will facilitate the use of confocal microscopy, fluorescent and
light microscopy, histopathology, specialized tissue staining methods, and image analysis by core users. The
Animal Models and Eye Organ Culture Core will facilitate the use of non-human primate, feline, rodent and
other animal models of ocular disease, the use of OCT, ERG, VEP to assess visual function, and the use of
other visual structure and function outcome measures.

Public health relevance
NARRATIVE Contemporary research in visual sciences requires access to modern quantitative and analytical technologies, the use of a variety of complex animal models, and state-of-the-art imaging. This Vision Science Core proposal encompasses all of these requirements to augment the already exceptional research capabilities of investigators at the University of Wisconsin-Madison. A fundamental difference in this revised application is the expansion of our quantitative molecular biology core to include access to the “Omics” facilities that are operated by the UW campus. Our plan is to provide Core users with a subsidy to facilitate their use of these facilities, which includes modern high-throughput and multi-plexing sequencing technologies, mass spectroscopy (including lipidomics and metabolomics), and proteomics. Additionally, the core itself has added laser-capture microdissection instrumentation and plans to acquire a SeaHorse XF analyzer to augment these capabilities. The imaging core retains its services for top-tier histopathology, while including access to high resolution confocal and live-cell imaging and conventional electron microscopy. Additionally, this core has added access to a new serial block face scanning electron microscopic facility that is co-directed by Dr. Mrinalini Hoon who is also a co-director of this part of our core application. Lastly, we retain our animal model core to provide world class expertise and access to the variety of complex animal models and ex vivo systems, ranging from rodents to non-human primates, that are essential to translational discovery in vision research. As a new initiative, this core is also the center of a new biobank of human ocular tissue and fluids that is being cataloged, stored, and made available to core users for research projects.